Software for Group Sequential Trials

DESCRIPTION (provided by applicant): Group sequential trials is the term used to describe clinical trials that take place over a period of time, with statistical analyses being conducted at various points over the course the trial. If it can be shown at an interim analysis that the treatment is effective there may be an ethical imperative to stop the study at that point, and for this reason group sequential trials are mandated by the NIH for certain types of studies including many in the fields of heart disease, cancer, and AIDS. The goal of this project is to develop software for planning and monitoring group sequential trials. Like other programs, this one will work with various types of effect size, will include modules for study design as well as for interim analyses, will allow the user to work with various algorithms and with various stopping rules. However, this program will differ from what is currently available in a number of critically important ways. First, it will feature a more sophisticated and realistic survival model. Other programs force the researcher to assume that the hazard rates are constant for the duration of the study. This program, by contrast, will allow the hazard rates and treatment effects to vary over time. Additionally, it will allow researchers to incorporate such factors as non-compliance and loss to follow-up and to competing risks. This will yield substantially improved estimates of the sample size required to yield a given level of power. It will also yield better estimates of the amount of information likely to be available at each of the interim looks, which is crucial for being able to plan the timing of the DSMB meetings and total study duration. Second, the program will feature a lucid, intuitive, and informative interface for data entry and a corresponding array of options for output. Finally, it will be affordable.